TASK ORDER 1R - ADMINISTRATION ACTIVITIES AND SUPPORT

The purpose of this task order is to provide technical support, management, and collaboration as associated with administrative functions and activities of the Clinical Research Support Services for the NIEHS Contract.
This Task Order will incorporate multiple CLINs. In addition to providing support for the core functions of the Contract, it is anticipated that this Task Order will also support discrete efforts that are related to the work, but may not warrant award of a separate Task Order, such as pilot, longitudinal, and feasibility studies, efforts of small size or duration, add-on studies, small projects, etc.
The work associated with the support of the core function activities of the Clinical contract will be provided under this Task Order CLIN1: Core Function Activities. Additional related work may be incorporated to this Task Order under separate CLINs. The specific aims of each project will vary but general support may include preparation of regulatory documents for Internal Review Board [IRB] and Federal Drug Administration [FDA] submissions, subject recruitment, subject enrollment, data and safety management and other protocol related activities.
The purpose of CLIN1 is to provide technical support, management, and collaboration as associated with core administrative functions and activities of the Clinical Research Support Services contract. Under CLIN1, the Contractor shall provide project administration and support to the work provided under other Task Orders in the contract.